Administrative Core

ADMINISTRATIVE CORE – ABSTRACT
The overall objectives of the Administrative Core are to: 1. provide administrative support for the Program; 2.
provide organizational support for the Program; 3. provide scientific management of the Program; and 4. provide
administrative services for the clinical trial conducted within the Program. The Program is a collaboration
between a strong team of investigators and multiple cancer centers and is led by two MPIs, Drs. Kimberly Leslie
and Jay Gertz, with outstanding leadership skills and synergistic expertise in endometrial cancer research. The
Program consists of four Projects and three Cores and is overseen by a Leadership Council comprised of PIs
and Project Leaders as well as the leader of the Diversity and Patient Advocacy Committee. The Program
benefits from the engagement and oversight of the Internal and External Advisory Boards. The principal
collaborating institutions are the University of New Mexico Comprehensive Cancer Center, the Huntsman Cancer
Institute at the University of Utah, the Holden Comprehensive Cancer Center at the University of Iowa, and the
University of Kansas Cancer Center. The cancer centers have generously pledged additional funds to
supplement the activities of the Program, including funding the acquisition of new preliminary data relating to
endometrial cancer prevention and treatment through a pilot project grant opportunity to be overseen within the
Administrative Core. By efficiently and effectively achieving these objectives, the Administrative Core will ensure
that our clinical trial meets enrollment milestones in terms of both numbers and diversity; trial participants receive
excellent care; Projects progress on time and within budget or are amended; results are reported accurately;
and interactions with the Cores and Projects are smooth and beneficial. The Administrative Core will help the
Program flourish as a result of visionary and collaborative leadership. The Program will benefit greatly from the
Administrative Core’s thoughtful communication, strong oversight and creative support.

Public health relevance
ADMINISTRATIVE CORE – PROJECT NARRATIVE Of all major tumor types, endometrial cancer is arguably the most preventable - but surprisingly, incidence and deaths from endometrial cancer are increasing every year. The goal of the Program Project, Advancing Hormone Therapy for Endometrial Cancer, is to prevent and treat this disease using progestins, which are derivatives of the natural tumor suppressor of the endometrium, progesterone. The Administrative Core will significantly enhance the communication and productivity of the research team, oversee all administrative tasks, and ensure equity, inclusion and all compliances.